Evaluation of an automated DNA extraction for food-borne pathogen isolates

Project Abstract Automated extraction of DNA for molecular testing has been high demand. Manual extraction of bacterial DNA for whole genome sequencing is still currently used in NGS protocols of FDA and CDC. In this proposal, we request funding needed to evaluate an automated extraction of bacterial DNA to strengthen capacity of our and other Vet-LIRN network laboratories. A reliable automated extraction of bacterial DNA for WGS will improve efficiency, consistency, and throughput. The proposed study will enhance the capabilities of the Vet-LIRN to respond quickly to food-borne related illness in animals, which will have important impacts for both human and veterinary health.

Public health relevance
Public Health Relevance Statement: Project Narrative Whole genome sequencing (WGS) using NGS technology is commonly used for investigation of food-borne illness caused by bacteria. Improving capacity for bacterial WGS in veterinary diagnostic labs for outbreak investigation is to support enhanced human and animal food safety. We propose to request funding to evaluate an automated extraction method to improve our capacity for outbreak investigation of food-borne illness and a generic SOP developed from this project will be shared with other network labs.